CANCER COMMUNICATION SYSTEM

The contractor shall disseminate and interpret information regarding the cause, prevention, detection and treatment of cancer to cancer patients and their families, the general public and health professionals.